Enrichment and Research Administration Core

The overarching goal of the Enrichment & Research Administration Core (ERAC) is to support the scientific
mission of the Dartmouth Cystic Fibrosis Research Center (DartCF): to foster a superior environment for
discovery of new principles of CF biology, epithelial function, microbial colonization, and host responses, and
their translation into clinical outcomes, in areas of interest to NIDDK. Launched in 2018, DartCF will continue to
support three Biomedical Research Cores. It will expand its pilot program to recruit new investigators and fund
new research directions, including CF gut dysbiosis, GI microbial communities, and liver function. It will also
support an intensive research development program and will leverage institutional resources for program
enrichment, including annual symposia and new training modules in best research practices. Working across
the basic and translational spectrum, these components will advance the identification and validation of new
therapeutic strategies in CF. Scientific leadership will be provided by Director Dean Madden, PhD, the DartCF
leadership team, Internal and External Advisory Committees, and an inclusive Faculty Council. The role of the
ERAC is to provide efficient scientific leadership, organizational support, and fiscal oversight for all Center
components. Building on strategies developed for other programmatic awards and deployed in year one of
funding, the ERAC will achieve the following Specific Aims: (1) To provide scientific leadership supporting all
DartCF members as they explore new high-impact research directions; (2) To support strategic research
development opportunities; (3) To facilitate robust scientific communication; (4) To offer streamlined
administrative and fiscal support, providing timely and accurate reporting to DartCF and institutional leadership
and NIDDK Program staff; and (5) To enrich the scientific and research environment by deploying institutional
resources. Each of these aims will advance the DartCF mission. Inclusive, experienced leadership will identify
and create new opportunities for Center faculty to pursue basic and translational research projects in CF, with
a goal of improving therapeutic options and patient outcomes. The education program will provide expert
guidance to our faculty, enhancing their research productivity and generating additional extramural support for
CF research. A weekly research-in-progress series, interspersed with invited seminars and an annual Dartmouth
CF Retreat, will sustain a highly integrated, interactive scientific community and stimulate the exploration of new
research directions. Together with the Biomedical Research Cores, pilot and core funding will both recruit faculty
to the Center and increase their ability to compete for extramural funding. Program leadership has a strong track
record of scientific collaboration and two decades' experience with multiproject awards. Leveraging these
skillsets, we have developed an Administrative Core committed to providing excellent organizational support to
the investigators of DartCF and to advancing its success as an NIDDK-supported CF Research Center.